Selection and Sensing Applications of DNAzymes Selective for Paramagnetic Metal Ions

Project summary / abstract The overall goal of this project is to develop and validate a novel class of fluorescent sensors for paramagnetic metal ions (PMIs, e.g., Fe2+, Fe3+, Mn2+ and Mn3+), and to use these sensors to provide deeper insight into the uptake and homeostasis of PMIs in bacteria and the role of PMIs in pathogenesis. PMIs are essential elements for both humans and bacteria; the availability of these metal ions is sharply limited for pathogens, as a part of a host defense mechanism known as “nutritional immunity”; the most well characterized examples being Fe and Mn sequestration during infection. Moreover, Fe and Mn-regulated pathways are closely linked with pathways involved in managing oxidative stress, as occurs in phagocytic respiratory burst. Despite the importance of PMIs in nutritional immunity and oxidative stress pathways, the precise mechanisms dictating nutritional immunity, bacterial uptake of PMIs, and the ability of certain bacterial strains to circumvent metal starvation and thrive are unclear. A major barrier to understanding these complex mechanisms is the lack of spatiotemporal detection of PMIs in their different OSs in living bacterial cells. This proposal seeks to overcome this major barrier by selection and characterization of PMI-specific DNAzymes, and subsequent development and validation of DNAzyme-based turn-on fluorescent sensors selective not only for different PMIs, but also different oxidation states of the same PMI in two model systems (Staphylococcus aureus and Escherichia coli). Since pathogenic bacteria such as S. aureus and E. coli are a major public health issue, especially due to the spread of antibiotic resistance, our ability to develop turn-on fluorescent sensors for the real time detection of PMIs in cells will overcome a major barrier within the field of nutritional immunity by improving our understanding of the uptake and homeostasis of PMIs in bacteria and the role of PMIs in pathogenesis. Ultimately, knowledge gained from these sensors could provide insights necessary to develop novel strategies to fight against bacterial infection. Because the major goal of this project is to develop fluorescent sensors for the intracellular detection of metal ions, it is crucial to first develop, test, and optimize these probes in vitro first, before applying them to the much more complex intracellular environment. As such, this project is highly dependent on the availability of a reliable and highly sensitive fluorometer for its successful completion. However, our current fluorometer, which was purchased in 2003 and has been actively used for >16 years, has become unreliable, requiring costly repairs because of lack of parts and technical support from the company who sold the fluorometer. As a result, the unreliability and costly repairs of the fluorometer has become a huge bottleneck in our project. Therefore, we are seeking supplemental funding to replace our outdated and aging instrument with a current model.

Public health relevance
Narrative We request supplement funding to purchase a current model of fluorometer to replace a 16-year-old fluorometer, whose unreliability and costly repairs have become a huge bottleneck in our project in developing and validating DNAzyme-based turn-on fluorescent sensors for simultaneous selective detection not only for different paramagnetic metal ions (PMI) such as iron and manganese, but also for different oxidation states of the same PMI. This funding will allow us to achieve the goal of providing deeper insight into the uptake and homeostasis of PMIs in bacteria and the role of metal ions in pathogenesis, which can form a strong scientific basis in our effort to find novel strategies to fight against bacterial infection.